Maryland Population Research Center

PROJECT SUMMARY
This application requests a fifth cycle of five-year NICHD Population Research Infrastructure Program support
to the Maryland Population Research Center (MPRC) at the University of Maryland (UMD). The MPRC is an
interdisciplinary center at the University of Maryland, College Park that supports the research of 84 population
researchers across 5 different schools or colleges and 16 departments or units. Over the next five-year period,
MPRC will support population research in the Primary Research Areas of Gender, Family, and Social Change,
Social and Economic Inequality, Health in Social Context, and Migration and Immigrant Processes, and will
support innovations in data and methods for population research across these substantive areas. This support
will be provided by three cores that are central to increasing the pace and impact of population science
research: Administrative, Development, and Scientific and Technical. These cores will provide research
infrastructure for population scientists, foster a vibrant, interdisciplinary intellectual environment, and promote
the development of junior and underrepresented minority scholars in population research. The cores will also
each provide resources to population researchers in institutions without Population Dynamics Center (P2C)
funding. The Admin core will support the preparation of grant applications, post-award project management,
and will provide services for other cores. The Admin core will deploy web-based tools to enhance Center
activities and will provide scholars effective means of managing research collaborations and disseminating
research. The Development Core will promote the intellectual community of population research at UMD
through seed grant programs, by organizing a weekly seminar series, workshops on focused topics, and by
organizing and co-sponsoring conferences and symposia. The Core also supports resident population scientist
and visiting population scientist programs that provide options of both a physical and a virtual home for
population researchers whose research productivity may be enhanced by the infrastructural and intellectual
resources of MPRC and UMD. Taking advantage of our location in the Washington, DC area, MPRC will
promote the research of our associates through engaging with the research and data activities of federal
agencies in the Washington, D.C., including through support to biennial workshops and conferences on time
use research using the American Time Use Survey and its international counterpart surveys. The Scientific and
Technical Core will manage the Center’s computing resources, and provide confidential, secure-data access,
both in-house and through facilitating and promoting access to campus-wide secure-data computing
infrastructure. It will also provide statistical computing short courses and consulting to support empirically-
focused population research.

Public health relevance
PROJECT NARRATIVE (Public Health Relevance) The MPRC promotes research that is central to the NICHD Population Dynamics Branch mission, in areas of demographic research, population and health, and reproductive health and HIV/AIDS research.